Using optical sensors to measure synaptic glutamate release from retinal rod photoreceptor cells

Project Summary
Light responses generated by photon capture in rod photoreceptor cells must be transmitted at their
synapses to downstream neurons. Transmission at the ﬁrst synapse in the retina thus determines the
information about light available to the visual system. A remarkable ability of the human visual system is
the ability to detect dim light ﬂashes consisting of only a few photons. This sensitivity originates with the
ability of rods to respond to single photons but requires nearly noiseless transmission of small single
photon responses through the retina and brain. A critical ﬁrst step in this process is transmission from
rods to rod bipolar cells. Fluorescent glutamate sensors have provided important insights into circuit
mechanisms in other parts of the retina and CNS but have not been successfully used to study release
from rods. To overcome this, we developed a genetically-modiﬁed mouse line allowing constitutive
expression of an improved glutamate sensor, iGluSnFr3, speciﬁcally in rods. In this proposal, we plan
to characterize the strengths and limitations of using iGluSnFr3 to measure glutamate at rod synapses.
Electrophysiological recordings from tiny mammalian rods are exceptionally challenging so providing
an optical approach for studying glutamate release from rods will pave the way for future work by
many laboratories on basic and disease-related questions of photoreceptor function. Release rates at
rod synapses are slow and this makes it diﬃcult for a post-synaptic rod bipolar cell to discriminate a
lengthy random pause in release from a genuinely lengthy pause caused by a single photon
response. One way to overcome this would be for release to occur at regular, not random, intervals.
Results from our laboratory using an indirect measure of glutamate release suggested that synaptic
release from rods is surprisingly regular, not random as generally thought. Optical measurements
using iGluSnFr3 oﬀer the opportunity to directly measure release from dark-adapted rods in intact
retina and test the physiological signiﬁcance of this regularity. Establishing that release from rods
occurs at regular intervals would be a fundamental change in our understanding of how visual
information is encoded at the ﬁrst synapse in the retina and suggest many future experiments.

Public health relevance
Project Narrative This project combines state-of-the-art physiological approaches to address important unanswered questions in the neuroscience of vision. Proposed studies will fill important knowledge gaps about how light-sensitive rod photoreceptor cells of the retina transmit information to the rest of the visual system, allowing us to detect lights as dim as single photons. An in-depth understanding of retinal mechanisms of vision is in turn critical for the proper diagnosis and treatment of retinal disease and therapeutic restoration of vision.